African American Cardiovascular pharmacogenetic CONsorTium (ACCOuNT): discovery and translation

The Administrative Core will provide the necessary leadership and administrative support structure to ensure the effective coordination of the Consortium’s activities. The Core will provide scientific leadership and oversight; facilitate interactions among Projects and Cores; provide necessary administrative assistance to investigators and all participating institutions and collaborators; manage all Consortium finances; and convene all necessary meetings of the Consortium. The following are the 3 aims of the Core: 1) Provide overall support to ACCOuNT and to each individual Core and pilot/full research project via close interaction with Core and project leadership as well as all proposed committees; 2) Facilitate communications across the ACCOuNT sites, the Community and Stakeholder Advisory Board (CSAB), the Implementation Advisory Counsel (IAC), the Scientific Advisory Committee and the Steering Committee (SC); and ensure iterative and robust evaluation throughout all activities related to this Core and the overall U54. We will have monthly Consortium meetings, which will allow all active Center investigators to present their research findings, as well as, monthly EC meetings to review operational and budgetary issues. In addition, we will organize an annual meeting of the full Group, including the Steering Committee, with the first meeting planned for the summer of 2017 (year 2 of the grant). In summary, the Administrative Core will maintain an appropriate balance between rigorous timelines and dynamic flexibility, based on changing scientific goals of ACCOuNT.